Gene Delivery

Project Summary Gene Delivery Core
Vision research has benefited enormously by the advent of gene delivery technologies, aimed at
understanding the development, physiology, and pathology of the visual system, and in
developing strategies for treating ocular disease. Especially important have been advances in
AAV based gene therapy, directed evolution of new AAV capsid variants, restoration of retinal
responses in degenerative diseases by optogenetic proteins, and CRISPR/Cas9 based gene
editing technology for editing endogenous genes in the eye and the brain. Over the past two and
half decades, the Gene Delivery Core (GDM) has played an essential role in helping our Vision
Science researchers employ these technologies, fostering collaboration among labs, and
attracting new labs into pursuing questions that are relevant for vision science. Our goal in the
next funding period is to continue providing this essential service to Core investigators, their
labs, and the larger Vision Science community at UC Berkeley. The aims of the Core are 1)
Design and produce viral vectors for Vision Science researchers, 2) Introduce new gene delivery
technologies to Vision Science researchers, 3) Assist UC Berkeley Vision Science researchers in
generating transgenic animal models.

Public health relevance
Narrative Gene Delivery Core The Gene Delivery Core will serve the UC Berkeley Vision Science community by designing and producing viral vectors, introducing new gene delivery technologies to users, and assisting researchers in generating transgenic animal models.